Biostatistics, Epidemiology, and Research Design Core

ABSTRACT – BIOSTATISTICS, EPIDEMIOLOGY, AND RESEARCH DESIGN CORE
The BERD Core has helped to transform clinical and translational research in Rhode Island during Phase I of
Advance-CTR providing guidance in study design, data collection, data analysis, framing of results and drawing
reasoned inferences. BERD has also provided training in research principles and a variety of essential tools.
The result has been a markedly improved quality of research applications, increased diffusion of research
support to young investigators, a high level of satisfaction and excitement in the research community, and a
desire for even more support.
In Phase II, the BERD Core will expand its support into new areas, using new modalities and reaching out to
new audiences. We will work to connect the many isolated groups of analysts with whom we have connected
who are embedded within Advance-CTR partners. Our goal is to evolve toward a sustainable infrastructure that
meets the research needs of the entire state. By capitalizing on the existing resources of partner institutions, our
efforts will help maximize the value of their existing investments as well as point to gaps in needs that can be
filled through collaboration or expansion. Our centralized web portal already efficiently matches investigators to
a highly qualified and diverse set of experts with long-term consultative experience and a reservoir of faculty
research leaders skilled at teaching. We will expand consultative and training support, including adding a second
Core Co-Lead, for designing and analyzing qualitative and mixed methods data. To increase enrollment and
boost retention for training, flipped and asynchronous online modalities will be emphasized. The Advance-CTR
website will be expanded to host educational pages. In addition to continuing support for the Pilot Project
Program, Professional Development and Biomedical Informatics, Bioinformatics, and Cyberinfrastructure
Enhancement (BIBCE) Core, we will collaborate with the new Community Engagement and Outreach Core to
develop strategies to increase community participation in study design and data collection, design studies that
properly address the health needs of the community and create results presentations that inform community
decision making. To accomplish these goals, we propose the following Specific Aims.
Specific Aim 1: Provide easily accessible, multidisciplinary collaborative support for quantitative and qualitative
research design, analysis, interpretation, and dissemination that can work seamlessly with and within existing
health research structures.
Specific Aim 2: Provide training in study design, epidemiology, biostatistics and qualitative and mixed methods
to clinical and translational researchers and research staff, delivered in a variety of formats, both synchronous
and asynchronous (in-person and remote), using the latest educational methods and technologies.
Specific Aim 3: Facilitate the development and widespread dissemination of innovative design and analytic
methods and tools for clinical and translational research.